PARTIAL SUPPORT OF BLUEPRINT FOR A NATIONAL PREVENTION INFRASTRUCTURE TO ADDRESS BEHAVIORAL HEALTH DISORDERS: A CONSENSUS STUDY

PARTIAL SUPPORT OF BLUEPRINT FOR A NATIONAL PREVENTION INFRASTRUCTURE TO ADDRESS BEHAVIORAL HEALTH DISORDERS: A CONSENSUS STUDY.